Research Program: Cancer Immunology

PROJECT SUMMARY: CANCER IMMUNOLOGY (CI)
Over the past decade, immunotherapy has emerged as an established modality that is revolutionizing the
treatment of many cancers. The Cancer Immunology (CI) Research Program has focused on genetically
manipulating T cells, applying new principles of synthetic biology, and combining engineered T cells with small
molecules and antibodies to broaden the applications and improve the safety and efficacy of adoptive
immunotherapy. Despite the success achieved with immunologic approaches in treating some malignancies,
major gaps exist in our current understanding of the complex relationship between progressing tumors and
host immunity, and these must be understood and overcome to achieve the potential of immunotherapy in
many common cancers. The CI program will focus on systematically tackling these barriers to eradicating
tumors using a variety of immunotherapeutic modalitie alone and in combination. The specific aims of CI are
(1) to develop effective and safe cellular immunotherapies for adult and pediatric hematologic malignancies
and solid tumors, (2) to identify and overcome the barriers to immune-mediated tumor eradication using clinical
specimens and preclinical models, (3) to translate discoveries in basic immunology and synthetic biology to
novel clinical applications in cancer immunotherapy.
The Cancer Immunology (CI) program currently has 39 members from 11 departments and divisions and 4
Consortium institutions. Nineteen members have primary appointments at Fred Hutch, 12 members at
University of Washington, and 8 members at Seattle Children’s. Fourteen new faculty members joined this
program in the last cycle. The current research support of CI members is $23.4M (direct costs) in research
grant funding, of which $4.4M (19%) is from the NCI and $7.8M (33%) is peer reviewed. The Cancer
Immunology program published a total of 470 papers in the last grant period, of which 14% were intra-
programmatic, 49% were inter-programmatic, and 50% had external co-authors. Program members have
utilized all 12 of the Consortium Shared Resources. This P30 grant also assists this program by providing
administrative and logistical support for CI meetings, pilot funding for new research projects, and recruitment
resources for new faculty.

Public health relevance
Not applicable to P30 CCSG as stated in the FOA PAR-17-095.